Nutrition Obesity Research Center at Harvard

DESCRIPTION (provided by applicant): The administrative structure of the NORC-H is depicted in FIGURE 4. The Center will continue to be organized and supervised by an administrative core including the Director and Associate Directors, with the Center executive administrator and secretary in support. The role of these individuals in the Center is briefly summarized.

Public health relevance
RELEVANCE (See instructions): Studying the role of nutrition in care of disease will improve disease management. Attracting basic scientists to nutrition-research will help determine the role of nutrition in health.